Innovative Minimal Contact Therapy for Reducing TMD Pain

[unreadable] DESCRIPTION (provided by applicant): TMD is a highly prevalent (i.e., up to 15-20% among women of reproductive age) chronic pain syndrome with profound consequences including disability, psychosocial dysfunction, and reduced quality of life. While psychosocial interventions have shown tremendous promise in reducing TMD symptomatology, standard cognitive-behavioral treatments for pain are costly and time-consuming to administer. As a consequence, significant interest has been generated in the development of interventions that minimize the logistical burdens on healthcare providers and patients (e.g., "minimal-contact", "self-help", and "brief treatments"). While these treatments are widely used in the context of certain conditions (e.g., arthritis), their application in TMD has been minimal. Moreover, none of the few existing studies of psychosocial interventions for TMD make explicit use of social support, a powerful intervention with benefits for many chronic conditions. Thus, the principal goals of the present proposal are as follows: (1) to develop a minimal contact/home-based psychological intervention based on cognitive-behavioral principles for pain management that also makes explicit use of social support, and (2) to test the efficacy of this intervention, using an appropriate control group, in reducing pain and improving functioning. [unreadable] [unreadable]